Centriole assembly and function for centrosome and cilia biology

PROJECT SUMMARY/ABSTRACT
Overview. Centrioles, and the centrosomes they scaffold, organize the cell, and provide the foundation for
development and tissue homeostasis. To do this, centrioles exert control over the cell's microtubule (MT)
network, providing a micron-scale framework for intracellular trafficking, intracellular and extracellular signaling,
genome segregation, cell morphology, and cell mobility. To perform these roles, centrioles change through the
cell cycle via the processes of new centriole assembly and modulations to scaffolding functions. During a
normal cell cycle, centrioles nucleate the sensory and signaling compartment of cilia in G0/G1, duplicate
coincident with the genome during S-phase, and organize the mitotic spindle during mitosis. In cancer and
Trisomy 21 (the cause of Down syndrome), these mechanisms are disrupted. In specialized multiciliated cell
types, centrioles nucleate motile cilia which generate fluid flows necessary for reproduction, development, and
respiratory airway function. How centrioles are controlled, function and resist mechanical forces remain poorly
understood.
Goals for five years. We aim to dissect poorly understood mechanisms in how centrioles duplicate, how MT-
based intracellular trafficking and cilia are controlled by centrosome protein dosage, and how centrioles
provide the foundation for mechanical forces from motile cilia. We will investigate novel controls of centriole
duplication either through spatial distributions of regulatory factors or through mRNA metabolism that
generates functionally different proteins from the same gene. We will determine how imbalances in centriole
number and centriole protein dosage, as observed in cancer and Trisomy 21, impact cytoplasmic MTs and
intracellular trafficking for primary cilia formation and signaling. Finally, we will illuminate how centrioles act as
force capacitors for motile cilia through connections to neighboring centrioles and the cell cortex and ask if they
transmit forces back to cilia. These projects will establish the fundamental mechanics of centrioles as they
assemble primary cilia for signaling and motile cilia for hydrodynamic flow.
Vision for program. Discoveries in the fundamentals of centriole and centrosome biology, focusing on MT-
dependent trafficking and mechanical force resistance, will have broad implications for understanding aspects
of development, mechanobiology, and disease. Changes in RNA metabolism have a critical role in
development, and by establishing mRNA processing events that affect centrioles and the MT network we
anticipate identifying targets important for specialized cell types that utilize their MT networks in very different
ways. Furthermore, our current studies in Trisomy 21 are pointing toward exciting future directions for
understanding the cellular basis of cardiac, immune, and secretory cell systems directly impacted in Down
syndrome.

Public health relevance
PROJECT NARRATIVE Centrioles and centrosomes are ubiquitous and ancient macromolecular structures that are altered both in cancer cells and Trisomy 21 cells from individuals with Down syndrome. Our current research aims to understand the control mechanisms that centrioles and centrosomes exert on primary and motile cilia. We will illuminate fundamental events that contribute to cancer and Down syndrome and future studies will test whether these events are promising targets for therapeutics.